Dietary modulation of Paneth cells

ABSTRACT
One of the underappreciated effect of obesity is the repression of gut innate immunity, as we recently showed
in overweight/obese patients, using Paneth cell phenotype (as a surrogate for Paneth cell function) as a proof-
of-concept. Wild type mice fed with western diet (WD) also developed Paneth cell defects. We further showed
that WD consumption results in microbiota-mediated increase in deoxycholic acid (a secondary bile acid),
which activates the FXR pathway in the ileum. FXR activation in the intestinal epithelium, as well as FXR-
mediated type I interferon activation in myeloid cells, collectively trigger Paneth cell defects. The critical
questions that need to be addressed before translating these findings to clinic include how individual dietary
components that impact Paneth cell function, and if long-term WD consumption renders Paneth cell defects
irreversible to dietary switch alone. Our long-term goal is to dissect the cellular and molecular mechanisms of
how WD consumption affect the intestinal stem cell (ISC) and Paneth cell biology. These discoveries will
facilitate design of trials for obese patients with gut innate immunity dysfunction. The objective of this proposal
is to determine how WD consumption induces Paneth cell abnormality. The central hypothesis is that long-term
consumption of dietary fructose result in Paneth cell defect due to diminished capacity of Paneth cell
replenishment (by Paneth cells themselves and/or intestinal stem cells [ISC]). Our rationale is that identification
of the mechanism(s) to restore Paneth cell function will offer new therapeutic opportunities for many patients,
such as those with inflammatory bowel disease and graft versus host disease, of which Paneth cells play a
critical role in pathogenesis. Our preliminary data suggest that dietary fructose consumption alone is sufficient
to trigger Paneth cell defects, and that Paneth cell defects after long-term (≥12 months) WD consumption are
not reversible by switching to standard diet. Our specific aims will test the following hypotheses: (Aim1) How
dietary fructose directly induces Paneth cell defects; (Aim 2) Long-term WD consumption will impair the
capacity of Paneth cells as well as ISCs to repair and replenish defective Paneth cells. Upon conclusion, we
will understand the role for dietary fructose in modulating Paneth cell and ISC function. This contribution is
significant since it will establish intestinal epithelial fructose catabolism and associated genes as therapeutic
targets. The proposed research is innovative because we investigate how long-term exposure to poor diet on
gut innate immunity, a heretofore-unexamined process. We also use state-of-the-art ISC culture system and
scRNA-seq and scATAC-seq techniques to identify molecular and cellular targets that affect Paneth cell and
ISC functions. Identifying the mechanisms of how diets regulate a key disease-relevant cellular phenotype will
provide insight into other inflammatory disorders.

Public health relevance
PROJECT NARRATIVE: The proposed research is relevant to the public health because obesity, which is increasing in prevalence worldwide, represents a major national cost measured by both patient quality of life and economic burden. One under explored areas in obesity-related pathophysiology changes is the defects in mucosal innate immunity as we have previously shown, using Paneth cells as a proof-of-concept. Identifying the causes of how obesogenic diet reduces Paneth cell function will provide insight into the development of intervention strategies for diseases of which Paneth cells play a critical role, such as inflammatory bowel disease, graft versus host disease, and gut infection. Our preliminary data suggests that diet-induced obesity (due to western diet [WD] consumption) leads to Paneth cell dysfunction in both humans and mice by activating FXR signaling in the intestinal epithelium and myeloid cells. Upon conclusion, we will establish how dietary fructose (a key ingredient in WD) triggers Paneth cell defects, and determine the mechanisms by which Paneth cells themselves and intestinal stem cells repair defective Paneth cells in the context of long-term WD/HFrD consumption. Our data will help design intervention strategies for obese patients with Paneth cell defects.